YALE CANCER CENTER CALABRESI IMMUNO-ONCOLOGY TRAINING PROGRAM

Summary: Therapy for multiple types of cancer has evolved dramatically in the last decade with the emergence
of immune modulation therapies that induce responses and prolong survival in the adjuvant and metastatic
settings. It is now apparent that these advances are only the vanguard in a rapidly evolving field. Investigators
from Yale School of Medicine have played key roles in both pre-clinical and clinical advances in immuno-
oncology. Continued advancement requires better understanding of primary and secondary resistance to
immune therapy, the biology of immune suppression in the tumor microenvironment, rational drug combinations,
studies of drug toxicities and new trial designs specific for immune therapies. Hence, there is an urgent need to
train junior investigators to conduct patient-oriented cancer immunology and immunotherapy studies to further
accelerate these advances. Our Immuno-Oncology Training Program (IOTP) addresses this critical need by
training MD or MD/PhD Scholars in clinically-relevant immuno-oncology and translational immunology. At least
five junior faculty scholars are enrolled at any given time. IOTP is distinct from existing training programs at Yale
as it is the only one to specifically focus on training of junior faculty in patient-oriented research in immuno-
oncology and immunotherapy. IOTP has been highly successful to date in developing a diverse pool of
independently funded researchers who capitalize on the wealth of expertise at our institution in immunobiology
and immunotherapy. IOTP faculty have extensive track records of mentorship and are actively pursuing research
in these areas. IOTP is supported by the Yale Cancer Center (YCC) and synergizes with the Yale Center for
Clinical Investigation, home to our CTSA grant, which provides some foundational courses. Key distinguishing
features or IOTP are didactic and practical training developed specifically for this program including courses on
basic immunology and cancer immunology, immunotherapy-specific clinical trial design, the Cancer Immunology
Forum and an individually tailored, two-year Translational Immuno-oncology research project encompassing
laboratory and/or clinical research. New for the next funding period include a course on computational
immunology, endeavors for training in mentorship and community outreach and engagement initiatives. Each
scholar has a panel of mentors. Junior faculty within five years of appointment at Yale School of Medicine are
eligible, with up to five scholars appointed at any one time, and an additional scholar will be funded by YCC. The
program is led by an Executive Committee comprised of the PI (Dr. Harriet Kluger, YCC Associate Cancer Center
Director for Education and Training), the Co-Director, Dr. Diane Krause, MD, PhD, an expert on cellular
therapies, David Stern, PhD, Chair for Curriculum Development and Roy Herbst, MD, PhD, Chief of Oncology
and Associate Cancer Center Director for Translational Research. In summary, the IOTP draws upon an area of
profound institutional strength and enables YCC to focus specifically on cross-disciplinary training of scholars in
Cancer Immunotherapy to meet the increasing need for cancer immunology experts and researchers.

Public health relevance
Project Narrative: Immune therapies have resulted in prolonged survival for patients with various types of cancer, and are changing the landscape for cancer research and cancer care. Many of the major advances were led by scientists and clinical researchers at Yale School of Medicine. We propose to continue to capitalize on this expertise as well as the rich resources available at Yale to train the next generation of Cancer Immunologists and Immunotherapists capable of conducting translational research to advance patient care.